Functional Analysis of Information Processing in the Peripheral Olfactory System

Project summary
Sensation leads to perception and guides behavior. Information about the external world is first received by our
sensory organs, then preprocessed and reformatted by subcortical structures prior to reaching the cortex where
a percept is potentially formed. In olfaction, information reaches the cortex after only two synapses. Despite the
critical role of olfaction for animal behavior across phyla, we still have a limited understanding of the principles
of information processing in this sensory system. In mammals, inhalation of odors induces broad patterns of
spatiotemporal activity across an array of glomeruli in the olfactory bulb, which in turn evoke complex activation
patterns in second order neurons, the Mitral and Tufted cells (MTCs). These cells are embedded in a local
network of inhibitory neurons and transmit information to higher brain areas. The goal of this proposal is to
characterize the transformation of odor responses from glomeruli to MTCs in awake animals, explore the
mechanisms underlying this transformation, and reveal its significance for information processing.
Our proposal capitalizes on recent technological advances that overcome experimental limitations that have
hampered progress in the field. First, we have developed a method for 2-photon calcium imaging of glomeruli
and MTCs using fast indicators to record neuronal activity with temporal resolution comparable to
electrophysiological recordings. Second, we currently can record responses of both glomeruli and MTCs in the
same animal to hundreds of odor stimuli presented over multiple sessions. And third, we have developed a
method for identification and characterization of functional connectivity between glomeruli and MTCs, by
combining 2-photon imaging of MTCs with optogenetic pattern stimulation of glomeruli.
Using this approach, we will characterize the responses of MTCs that are functionally connected to defined
glomeruli using a large battery of odor stimuli. This will allow us to analyze the relationship between the response
tuning of identified MTCs and the responses of the large glomerular array. Next, we will gain insights into the
mechanisms responsible for shaping MTCs responses by optogenetic probing individual connections between
glomeruli and MTCs in the presence of odor stimuli. Finally, we will test the idea that the transformation from
glomeruli to MTCs plays a role in concentration invariant odor recognition by analyzing both glomeruli and MTC
response invariance to changes of odor concentrations.
The proposed experiments will generate fundamentally new insights into the rules governing sensory
transformations in the peripheral olfactory system and will provide powerful new tools for the study of olfactory
function in mammals.

Public health relevance
Project Narrative A fundamental question in neuroscience is how the nervous system processes information under normal and pathological conditions. Olfaction is the last frontier of our senses and we still lack an understanding of basic principles of how olfactory information is processed by the brain. The experiments described in this proposal examine the nature and neural mechanisms of the information processing at the peripheral olfactory system and the insights from this work should lead to a better understanding of the general principles of object recognition in olfaction and other sensory systems.